Assessing the long-term impacts of the COVID-19 pandemic on disparities in cancer screening and follow-up (RESTORE)

PROJECT SUMMARY/ABSTRACT: The COVID-19 pandemic has led to dramatic reductions in cancer
screening and follow-up services. During the early months of the pandemic, national organizations
recommended postponing all routine cancer screening, resulting in dramatic reductions in adult primary care
and specialty care visits; current rates remain far below pre-pandemic levels. Modeling suggests that these
reductions will result in over 57,000 missed cancer diagnoses and 10,000 excess deaths over the next
decade. However, these models are largely informed by data sources made up predominantly of insured
patients and lacking race/ethnicity information. Thus, more information is needed to understand the
strategies and resources need to support the recovery of health systems and communities that have been
most impacted by COVID-19. The effects of the pandemic on cancer screening uptake may be particularly
profound for patients served by resource-limited federally qualified health centers (FQHCs), which deliver
services a large share of patients with incomes below the federal poverty level and who are Latinx. Latinx
populations already have some of the lowest rates of cancer screening and follow-up care in the United
States and are likely to experience the largest reductions in care and slower return to normal following
COVID-19. This is, in part, because their communities have been hit particularly hard by COVID-19 (e.g.
high rates of COVID-19 infections and hospitalizations and job loss) and they may fear returning for
preventive care even when medical authorities have deemed it safe. Our proposed mixed-methods study will
estimate the impact of the COVID-19 pandemic on rates of cancer screening and follow-up in patients
served by a large, diverse FQHC (Aim 1), and estimate impacts on cancer outcomes (e.g. changes in life
years gained, cancers prevented, and late-stage cancer incidence) in the FQHC population building on
models developed by the CRC-SPN Cancer Intervention and Surveillance Modeling Network (Aim 2). Finally,
we will gather qualitative data from clinic staff and patients to identify opportunities to improve post-pandemic
cancer preventive care delivery for adults served by FQHCs (Aim 3). There is a critical need to understand
the long-term impacts of COVID-19-care reductions on vulnerable populations and identify opportunities to
meet the ongoing cancer prevention needs of patients served by FQHCs. We will collaborate with national
stakeholders to develop FQHC-specific guidance to inform future interventions to support recovery from
COVID-like care disruptions Thus, our findings will support access to care and reduction of health disparities
for communities most impacted by COVID-19.

Public health relevance
PROJECT NARRATIVE Not enough people receive the cancer screenings (such as colonoscopies and mammograms) that they need, and COVID-19 has made getting these services more difficult. Our study will examine the impacts of COVID-19 on cancer screening and follow-up care for low-income and Latinx adults served by community health centers. Our goal is to guide community health centers in recovering from COVID- 19, ensure more equitable access to cancer screening, and save lives from preventable cancers.